FY22 Facilities Task Order B – Refurbishment and Infrastructure Projects focused on Facility Improvements within the NCI at Frederick Campus

Statement of Work Appendix: General Requirements FY22 Facilities Task Order B – Refurbishment and Infrastructure Projects focused on Facility Improvements within the NCI at Frederick Campus1. General RequirementsIn accordance with FFRDC SOW, Maintenance plans shall be compatible with elements of the current Interagency Agreement including any revisions thereto, between the U.S. Army Garrison (USAG), Fort Detrick, and the NCI at Frederick with the Contractor performing those functions designated as the responsibility of the NCI at Frederick. The Contractor’s work and responsibility shall include all planning, programming, engineering, maintenance, administration, and management necessary to provide work as specified. The Contractor shall ensure that staffing hours and levels are sufficient to meet the Government’s needs. The work shall be conducted in accordance with the FFRDC SOW, Exhibit 1, Regulations/Certifications/Accreditations/Guidelines. 2. Facility Operations & Management of Planned WorkThe Contractor shall work closely with the Government to determine needs and priorities associated with customer requirements. The Contractor shall coordinate with EHS during project concept, design, and closeout to ensure project milestones submitted in project schedules are reflective of both FME and EHS requirements. a) Planned Work ManagementThe Contractor shall have the authority to manage all aspects of work orders to include, but not limited to, the use of approved project budget, schedule, and project quality. The Contractor shall estimate the project contingency needs using qualitative and quantitative metrics, approval must be obtained in accordance with the task order terms and conditions prior to any release of contingency funds. The Contractor shall keep the customer and FME COR informed of project progress. All project changes must follow Facility Change Management process. During task order performance when an impact to scope, cost, schedule or performance is identified the Contractor shall notify the Government by inclusion in the monthly progress notification. If the critical path is changed the notification shall include an explanation of the cumulative events that resulted in the change, Fragnet, and risk mitigation strategy including schedule recovery and/or acceleration. Contractor shall coordinate across all directorates to ensure each project has an integrated Master Schedule. b) Planned Work CloseoutThe Contractor shall work collaboratively with the FME COR to establish standard practices for project closeout. The Contractor shall consistently apply closeout practices. Contractor shall ensure project
09/26/2019
2
close-out consideration in scope/cost/schedule account for processes across all Contractor business directorates.
3.Facility Strategic Planning
As a component of the development and ongoing growth and refinement of the Facilities Operations Manual required per the parent IDIQ, the Contractor shall continually assess and analyze all aspects of Facility, Maintenance and Engineering activities. The Contractor shall seek to consider procedures to improve efficiency in facilities, maintenance, engineering, and renovation/ alteration/ maintenance/ refurbishment/ improvement projects. The Contractor shall to seek to identify improvements in all aspects of performance that will increase the effectiveness or efficiency of contract performance. Identified improvements shall align with Government requirements, customer feedback, and stakeholder input.
4.Quality Assurance/Quality Control (QA/QC)
Contractor shall develop and maintain a baseline program of quality assurance (QA) and quality control (QC) that will document performance and quality standards, and management controls and assessment techniques to ensure components, services, and products meet HHS/NIH/NCI’s design criteria and other governing and applicable specifications. The Contractor shall identify policies and procedures to improve performance and efficiencies in all project areas. The Contractor shall establish and maintain an effective quality control (QC) system. QC consist of plans, procedures, and organization necessary to produce a product which complies with the Contract requirements.
Contractor shall provide Construction Quality Management (CQM) plan to ensure that work is performed according to plans and specifications, on time, within a defined budget, and a safe work environment. Contractor shall provide a detailed Quality Control Plan (QCP) for all projects > $50,000.00, contractor shall identify certified Quality Control Manager for all projects >$1m. The contractor has primary responsibility for compliance with plans and specifications.
5.Cost control (Estimating
The Contractor shall use historical data, market analysis, and “RS Means” software to develop cost estimates of any change requests and/ or impact analysis reports. The Contractor must adhere to the requirements established in the DRM (Section 1.6.3). The Contractor shall also follow American Society of Professional Estimators (ASPE) methodology.
6.Meetings
The following meetings between the Contractor and NCI designated representatives are held, non-severable projects awarded on task orders shall be included in content and discussions as applicable:
1)FME Operations Meeting (Weekly)
This meeting to include FME, MOSB, and FME COR shall be held weekly to review and discussprogram operational priorities and performance.
2)Plan of the Week (POW) Meeting (Weekly)
09/26/2019
3
This meeting to include FME, EHS, Program Representatives, MOSB, OSO and FME and EHS CORs shall be held weekly to review status of all new work orders, work orders in development, and approved work orders.
7.Tracking and Monitoring of Metrics
Under the requirements of the NCI FFRDC Operational Task Order the Contractor and the FME COR shall identify Key Performance Indicators that have designated targets. Once identified, the Contractor shall track and monitor metrics to the identified KPIs. For planned work awarded under non-severable task orders, the Contractor shall track and monitor, at a minimum, the following metrics:
•Percentage of Work orders (WO) rescheduled from the initial approved schedule.
•Work order expenditure by type:
oGeneral Work Order
oInspection
oEmergency
oCorrective Maintenance
•Percentage of Planned WOs verses all other WOs
•Backlog (Funding threshold)
oSpecial Assists
•Work order backlog including 30+ days total and per shop
•Work order completion response time per shop
•Shop support to FME Planned Work Orders, hours and percent of total
8.Contingency
Contingency notifications shall include:
1-Narrative explanation of need for contingency use
2-Contingency log tracking each instance of contingency use, amount, subtotal, and remainingbalance
3-Contingency Index Calculation
•Contingency Index = Physical % Complete / % Contingency Expended.
4-Supporting documentation as applicable, including but not limited to:
•PCO
•RFIs
•Bulletins
•Submittals
•Change order code:
oAE error omissions
oUnforeseen site conditions
oUser directed change requests
•Inspections
•Schedule change -Fragnet
09/26/2019
4
Additional contingency requirements:
1.If LBR’s ‘Best & Final’ subcontractor award is lower than LBR subcontractor estimateper NCI award amt, then all excess funds must be returned to NCI controlled reservewithin 15 business days.
2.LBR Direct labor cannot use project contingency unless approved by NCI FME CORand CO.
3.NCI Reserves the right to request additional information